Humanitarian Health Care Network: Bringing the Most Vulnerable to Care

ABSTRACT
Thousands of migrants arrive yearly at the southern US border. While most are healthy, some
require urgent medical care due to emerging health conditions, exacerbated pre-existing
illnesses, injuries acquired during their treacherous journey, or undertreated, undiagnosed,
unrecognized chronic diseases. These conditions may receive attention along the border
through the assistance of a community-based organization working in isolation, relying on
volunteers. More often, medical needs remain unattended until care is obtained at the migrant’s
destination. This could include a child with a seizure disorder that is out of medications or a
pregnant woman in her third trimester who needs prenatal care to optimize her birth outcome
and her child's health. These newly arrived migrants may be among the most vulnerable with
cascading health disparities including limited financial resources, Limited English Proficiency
(LEP), and limited familiarity with our complex medical system that will make accessing timely
medical care extraordinarily difficult. With lives dominated by other pressing needs such as
establishing a home, finding a job, or enrolling in school, establishing care is a challenge.
Comprehensive data is limited on community health outcomes; however, considerable health
inequities are reported anecdotally. In collaboration with public and private partners, we aim to
foster a community-engaged research project to develop and coordinate a system that will allow
us to identify and connect to care for pregnant women and children with complex medical
needs. We believe we can structural changes that will improve health inequities in collaboration
with the many partners engaged in receiving arriving migrants.